Neurobiological mechanisms of Western diet-induced cognitive dysfunction

Project Summary/Abstract
The rise in obesity and metabolic diseases worldwide has dire consequences on public health.
Concomitant with this rise are changes in diet. Notably, consumption of highly palatable foods that are high in
saturated fat and refined carbohydrates – collectively referred to as the Western diet (WD) – has increased
globally 1,2. Because children are in key stages of development and reportedly obtain ~65% of their total energy
intake from such high-fat, high-sugar foods 3, they are especially vulnerable to the impacts of the WD 4,5.
Furthermore, emerging evidence reveals that WD consumption impairs neurocognitive processes, particularly
when consumed during early life developmental periods 6,7. These negative outcomes can occur independent of
obesity and metabolic dysfunction, and early life WD consumption preferentially disrupts memory processes
that rely on the hippocampus 8,9, a brain region classically associated with learning and memory function and
more recently with food intake control 10. However, the critical timing and duration of such dietary exposure
during childhood and adolescence are poorly understood. Further, the neurobiological mechanisms that give
rise to early life WD-associated hippocampal dysfunction remain elusive. One hypothesis is that the
microbiome may be functionally involved, as microbial taxa were previously shown to be causally related to
memory impairments associated with early life consumption of added sugars 11. An additional hypothesis is that
WD-induced hippocampal dysfunction may be caused, in part, by impairments in the acetylcholine system,
given that obesity-promoting foods have previously been shown to alter these systems 7,12,13 and that
acetylcholine has been implicated in novelty and contextual-based memory processes that are particularly
vulnerable to WD-associated impairments 14. Accordingly, this proposal builds off our preliminary results to
unravel the mechanisms by which early life WD consumption impairs hippocampal function. Results from Aim
1 will determine whether memory impairments associated with early life WD consumption can be pinpointed
to specific developmental epochs within the larger juvenile-adolescent period (early, mid, late, or the entire
juvenile-adolescent period). Aim 2 experiments will utilize bacterial genome sequencing analyses and
microbiome transplant approaches to determine whether the microbiome is functionally related to
hippocampal deficits from early life WD consumption. Finally, based off preliminary data, Aim 3 experiments
will utilize two complementary in vivo approaches (behavioral neuropharmacology and in vivo fiber
photometry) to reveal whether altered acetylcholine signaling is functionally implicated in early life WD-
induced hippocampal dysfunction. Collectively, the proposed experiments will make strides in identifying the
critical developmental periods and mechanisms by which early life WD consumption imparts long-lasting
hippocampal dysfunction.

Public health relevance
Project Narrative Consumption of a Western diet, characterized by foods that are high in saturated fat and refined carbohydrates, is contributing to the increased global prevalence of obesity. A growing body of research indicates that Western diet consumption, particularly when consumed during early life periods of development, is also causally related to memory deficits and other neurocognitive impairments independent of obesity. This proposal is designed to identify the critical developmental periods as well as the neurobiological mechanisms by which early life Western diet consumption imparts long-lasting neurocognitive dysfunction.